Project 2: OPC-NERVE

ABSTRACT: PROJECT 2 (OPC-NERVE)
While most patients with oropharyngeal cancer (OPC) present with near normal functioning at the time of
diagnosis, a growing number of survivors suffer profound disability from delayed onset of lower cranial
neuropathy (LCNP) as a latent sequela of curative radiotherapy (RT). By 5 years’ survival, our group published
that at least 5% of patients cured of OPC develop LCNP with cumulative lifetime risk exceeding 10%. LCNP is
associated with excess symptom burden, disrupting critical functions of eating, breathing, and speaking.
Crippling swallowing dysfunction manifest by LCNP results in refractory aspiration of food and liquids into the
lungs. The investigators published that delayed, typically lifelong feeding tube insertion, tracheostomy, and
pneumonia years after cure of OPC occur almost exclusively in survivors who develop LCNP. Our publications
report functional loss over time after LCNP despite standard therapies. New therapy strategies are badly
needed. LCNP is clinically detected a median of 5 to 8 years after RT after a “quiet period” of functional recovery.
There is currently no early indicator for this injury. Delayed identification means that muscle atrophy and
symptomatic functional injury is typically present at the time of diagnosis, limiting therapeutic potential. Our long-
term goal is to improve lifelong function and health after OPC through mechanistically targeted and technically
nimble surveillance and mitigation of LCNP. Our central hypothesis is that subclinical cranial neuropathy is
prevalent early and increases over time after OPC RT as an untapped target for proactive mitigation strategies,
and novel patient reported outcome (PRO) and non-invasive objective measures with remote monitoring
potential are sensitive clinical markers of LCNP. The objective of the proposed study is to analyze gold-standard
needle EMG and non-invasive nerve function measures as correlative procedures in an ongoing large-scale
OPC cohort that captures robust longitudinal PRO and functional data to: Aim 1: estimate rates of hypoglossal
neuropathy (per gold standard EMG) over first 12 years post-RT; Aim 2: provide clinic ready symptom-based
and non-invasive objective clinical markers of LCNP by examining: a) a candidate multi-symptom nerve score
from the MD Anderson Symptom Inventory – Head and Neck Module (MDASI-HN), b) high-density surface EMG
(HDSEMG) as a rapid, non-invasive neurophysiologic measure of hypoglossal neuropathy, and c) mobile app-
based speech acoustic measures; Aim 3: conduct a 3-arm feasibility RCT for go/no go decision on high-dose
steroid and behavioral therapies for subclinical EMG detected XII neuropathy. Building upon the infrastructure
of the MD Anderson OPC cohort and investigators’ track record of non-invasive signal measurement in the
tongue and supportive care trials in OPC, we are uniquely positioned to accomplish these complementary aims.
We expect this Project integrated within the OPC-SURVIVOR P01 has potential for practice changing insights
regarding time to nerve injury, non-invasive measurement, and earlier evidence-based mitigation.

Public health relevance
NARRATIVE: PROJECT 2 (OPC-NERVE) The incidence of highly curable oropharyngeal cancer is rapidly rising and there are more long-term survivors than ever. Radiation treatment is very commonly given at doses sufficient to cause crippling late cranial neuropathy (loss of nerve function controlling tongue and throat) that can progress to the point that it results in a loss of speech, lifelong feeding tube dependence or death from aspiration pneumonia years after cancer is cured. This application seeks to understand how abnormal nerve function in the tongue may be present and measured long before it is evident in clinic, and whether it is feasibility to offer earlier therapy to help preserve function before irreversible damage is done.